VANCOMYCIN ADMINISTERED DURING HEMODIALYSIS WITH CELLULOSE TRIACETATE DIALYZERS

This study is designed to further examine the pharmacokinetics of vancomycin in volunteers with renal dysfunction requireing hemodialysis with cellulose triacetate (CT) dialyzers. Vancomycin doses of 15 mg/kg and 30 mg/kg given during hemodialysis and 15 mg/kg given between hemodialysis treatments will be compared. The plasma and dialysate vancomycin concentration profiles over the 8 day study period will be determined.